Health AI and Data Science in Cardiovascular and Pulmonary Disease: Application and Bioethics (HARP-BIO)

PROJECT ABSTRACT
This is a renewal application from University of Colorado Anschutz Medical campus that expands the original
focus of our existing “PRIDE Academy: Impact of Ancestry and Gender on omics of lung diseases
(AGOLD)”. The new descriptive title is “Health AI and Data Science in Cardiovascular and Pulmonary
Disease-Application and Bioethics (HARP-BIO)”. In this renewal, we propose to continue program focus on
impact of gender and ancestry on interpretation of omics data but will now include data sciences in general,
artificial intelligence and machine learning and how biases inherent in coding or programming of computers
and/or instruments results in biased outputs and ultimately health disparities in pulmonary and cardiovascular
diseases. This topic is well aligned with NHLBI interest areas of “Emerging technology and informatics, such as
artificial intelligence/machine learning and Integration of wearable technology in research and clinical care” and
Genomics, “populomics”, and precision health to advance the science of tailored treatment approaches for HLBS
conditions. The overall objective remains the same: to introduce scholars from under-represented backgrounds
to various omics platforms and how data sciences should be used ethically, interpreted and applied when working
with under-represented populations. This academy will be housed at the Pulmonary and Critical Care,
Cardiology Divisions of Dept of Medicine and the Department of Bioinformatics using resources available through
the Centers for Personalized Medicine and Health Artificial Intelligence as well as the Center for Bioethics and
Humanities. Over the last 4 years, AGOLD has trained 18 scholars, all underrepresented in Science or Medicine;
all scholars received small research project funds leveraged to obtain additional extramural funds as well as
peer-reviewed publications. The Pulmonary Division has a distinguished record of training leaders in pulmonary
medicine and the new Bioinformatics Department has been instrumental in elucidating to what extent genetics
can explain health disparities in complex diseases, particularly asthma. We propose a PRIDE summer academy
that will include didactic and hands-on workshops in genomics and proteomics of lung and cardiovascular
diseases, ethical use of data sciences and machine learning and introduction of the concept of academic
“coaches”. A coach is not intended to supplant the mentor, but rather guide team members through the process
of successfully navigating the academic world using well-tested social science approaches. Through 2
consecutive Summer Academies, the scholars identify a mentor and mentoring team, receive instruction on
“omics” and ethical use of data sciences and artificial intelligence, are paired with coaches who ensure that
milestones are achieved; participate in grant-writing workshops and mock study sections; implement an
evaluation plan that measures how the program is achieving its objectives. By using the combination of coaching
and social science practices such as cultural capital and communities of practice that allow team members to
feel connected with each other, we will ensure their academic persistence and ultimate success.

Public health relevance
PROJECT NARRATIVE This renewal application for a PRIDE Academy: Health AI and Data Science in Cardiovascular and Pulmonary Disease: Application and Bioethics (HARP-BIO) will select junior faculty scholars under- represented in science and medicine and bring them for two consecutive summer academies at the University of Colorado Anschutz Medical Campus. Here, the scholars will be introduced to state-of-the-art multiomics approaches to study the impact of ancestry and gender on cardiovascular and pulmonary diseases as well as how biases in coding can influence artificial intelligence and machine learning outputs and contribute to health disparities. By examining biases in coding in artificial intelligence and machine learning we will generate fundamental information regarding these technologies and how to apply them ethically and equitably. Scholars will be mentored by experts in personalized medicine and bioethics as well as experts in cardiovascular and pulmonary diseases and will participate in career development activities including social science approaches to ensure scholars' long-term academic persistence. Our overall goal is to create a workforce of pulmonary and cardiovascular researchers who are as diverse as the communities they serve.